Imaging radiation-enhanced drug delivery for safer and more effective chemoradiotherapy

Locally advanced head and neck squamous cell carcinoma and anaplastic thyroid cancer
remain challenging to treat, with locoregional recurrence occurring in over 40% of patients with
the standard of care treatment that includes combinations of radiation therapy, systemic
chemotherapy, and surgery. Unfortunately, most systemic therapies used with
chemoradiotherapy (CRT) exhibit rapid and non-speciﬁc distribution throughout the body and
elicit oﬀ-target toxicities that limit their use and dosage. Although selective drug delivery to
tumor versus oﬀ-target tissues plays a major role in deﬁning the balance between eﬀectiveness
and toxicity, little data describe how fractionated radiation aﬀects the tumor microenvironment
to aﬀect drug delivery. This project will therefore evaluate how fractionated radiation aﬀects the
collection of properties that impact the “enhanced permeability and retention” eﬀect within the
tumor microenvironment, which deﬁnes how macromolecular biologic and therapeutic
materials are able to access tumor tissue. Aim 1 will combine in vivo radiologic imaging, highly
multiplexed microscopy, and functional perturbations on immune response behaviors to
quantify how local radiation reshapes the tumor microenvironment to inﬂuence passive drug
delivery in mouse and patient-derived models of cancer. Aim 2 will test whether long-
circulating chemotherapy can combine with standard CRT to synergistically and safely improve
responses. Preliminary studies have shown how new chemical strategies can activate long-
circulating drug-conjugates in situ following exposure to radiation, therefore leading to highly
selective drug action and synergistic eﬃcacy. We hypothesize i) that long-acting cytotoxic
payloads will more selectively accumulate in tumor tissue and exhibit a superior safety and
eﬃcacy proﬁle compared to traditional chemotherapy, and ii) that new radiation-activatable
drug delivery can dramatically expand the therapeutic window of CRT to improve local disease
control. This project will provide a foundation for understanding how cellular and molecular
responses to fractionated radiation impact drug delivery in the tumor microenvironment, and
will help establish the basis for clinical translation based on radiologic imaging and the next
generation of radiation-enhanced therapeutics.

Public health relevance
This project aims to use in vivo imaging to understand how fractionated radiation impacts the tumor microenvironment and the action of long-circulating radiation-activated chemotherapy at a single-cell level. The overall goal of the project is to evaluate the efﬁcacy and safety of new chemoradiotherapy strategies by understanding synergistic impacts on both drug delivery and cellular response.